Inflammation and Pathogenesis Training Program

Abstract
The major objective of this new training program is to produce skilled, rigorous, and creative scientists who will
make novel connections between inflammatory processes and human pathogenesis. The University of
Louisville is well-positioned to have high impact by selecting trainees with leadership potential from its existing
Integrated Programs in Biomedical Sciences (IPIBS) for continued training on research topics that bridge
microbiology and immunology. This interdisciplinary approach will bring together 35 faculty who are all highly
productive scientists with extensive mentoring experience, and well-funded research programs, focused on i)
inflammatory ontogeny and immune surveillance of cancer, ii) mechanisms of autoimmune disorders, iii)
cellular and molecular mechanisms of host-microbial interactions, iv) animal models of infectious disease, v)
the role of the microbiota in regulation of inflammatory diseases, vi) polymicrobial communities and
inflammation, and vii) inflammation-driven disease and its impact on host physiology. Pre-candidacy support
from IPIBS, in which all students receive stipends and benefits funded by the University of Louisville, includes
laboratory rotations, advanced didactic training in immunology; inflammation; microbiology; and pathogenesis.
Pre-candidacy training also includes research survival skills, including grant development and composition,
oral presentations, scientific writing and publishing, professional networking, along with extensive training in
the responsible conduct of research. To attain the highest positive peer-to-peer impact, each year two students
who have demonstrated exceptional performance while successfully completing their first two years of
graduate education as IPIBS Fellows, will be selected for two years of support from the T32 training grant.
Students from diverse backgrounds who show the most potential, based on their achievements as IPIBS
Fellows in graduate coursework, a qualifying exam, and in their research projects, will be selected in order to
foster their academic leadership skills and excellence as research scientists. This additional training will occur
through student organization of a program-specific discussion club, hosting two high profile speakers per year
in disciplines that highlight important relationships between inflammation and pathogenesis and rigorous
review of their research progress by a training mentor and dissertation committee. The program will be
overseen by two Directors working closely with a Steering Committee, including an independent evaluation of
the training program’s organization, leadership, objectives and outcomes by Internal and External Advisory
Committees.

Public health relevance
Public Health Relevance Inflammation is a multi-component process that helps protect the host from injury and infection under normal homeostatic conditions. However, inflammatory responses can also cause acute tissue damage or become established as chronic inflammation, which together contribute to many human diseases. It is essential to train a new generation of scientists with interdisciplinary expertise in microbial and inflammatory biological mechanisms in order to continue progress against pervasive inflammatory-based disorders.